Multifocal transcranial current stimulation for cognitive and motor dysfunction in dementia

PROJECT SUMMARY:
In older adults with mild dementia, disruption in the ability to complete instrumental activities of daily living
stems not only from memory deficits, but also from executive dysfunction which also impacts gait and balance.
There is thus an urgent need to develop safe, multi-component interventions designed to maximize functional
capacity in this vulnerable population by simultaneously targeting memory, executive function, and the complex
control of gait and balance. It is now well-established that memory and executive-motor deficits arise from
altered function within specific and spatially distinct brain networks, and, that different forms of transcranial
current stimulation can target these networks to provide symptomatic relief to this population. Parallel lines of
preliminary evidence specifically suggest that 1) transcranial alternating current stimulation targeting the left
angular gyrus (tACS) at gamma frequency can improve episodic and autobiographical memory; and 2)
transcranial direct current stimulation (tDCS) targeting the left dorsolateral prefrontal cortex can improve
executive function and gait performance, especially when older adults are walking while performing additional
cognitive tasks (i.e., dual tasking). At the same time, important technological advances have recently enabled
researchers to: study and optimize multi-channel stimulation montages (i.e., electrode placement and current
parameters) based upon individualized modeling of generated cortical electric fields; target more than one
brain network at the same time within the same montage; implement active-sham protocols that facilitate
double-blinding and control of the potential effects of peripheral stimulation; and safely deliver interventions to
participants within their own homes via remotely-supervised, caregiver-led administration of stimulation.
Building upon these preliminary studies and advances, we propose to conduct a phase II, randomized, sham-
controlled, double-blinded, parallel-arm trial to assess the separate and combined effects of tACS targeting the
left angular gyrus at gamma frequency and tDCS targeting the left dorsolateral prefrontal cortex on memory,
executive function, dual task gait, and instrumental activities of daily living in ambulatory older adults with mild
dementia (Specific Aim 1). Within this trial, we will also determine how much of the clinical effects of
intervention on memory on the one hand, and executive function and dual task gait performance on the other
hand, depend upon the amount of the electric field induced respectively in the left angular gyrus and the left
dorsolateral prefrontal cortex, as assessed by individualized e-field high-resolution modelling (Specific Aim 2).
This project is expected to demonstrate that tACS and tDCS can be combined into one single intervention to
optimize the functional impact of a home-based intervention for older adults suffering from mild dementia. It will
also provide insights into the specificity of mapping between brain networks and symptoms, and offer critical
foundation to enable personalized optimization of stimulation interventions within future trials.

Public health relevance
PROJECT NARRATIVE: In older adults, mild dementia is associated with impaired function within several brain networks that causes numerous symptoms including loss of memory, the ability to complete complex mental tasks, and the capacity to control one’s walking and thus avoid falling and fall-related injuries. This study seeks to assess the separate and combined potential of two different types of transcranial current stimulation (tCS), which are safe and noninvasive technologies that enable selective modulation of brain network function, to provide multi-symptom relief to older men and women with mild dementia. By using state-of-the-art technology to 1) stimulate more than one brain network at the same, and 2) study the relationship between the electrical fields created by tCS and the therapeutic benefit of this intervention for each individual, this trial is expected result in the development of tCS interventions that have maximal impact on daily life function within this vulnerable population.